Interrogating Mechanisms of Anti-tumor Immunity in Human Subjects and Murine Models of IDH-Mutant Glioma Treated with All-Trans Retinoic Acid and PD-1 Inhibition

Project Abstract
Diffuse gliomas are fatal brain tumors that respond poorly to current immunotherapies. Using
both mice models and human clinical trial data, we propose a series of experiments to identify
immune biomarkers and key immune cell types that predict tumor responsiveness to therapy.
These results will further our understanding of brain tumor biology and inform the future
development of new treatment modalities.

Public health relevance
Project Narrative Recurrent mutations in Isocitrate Dehydrogenase 1 and 2 (IDH1/IDH2) drive several epigenetically dysregulated solid and hematological malignancies, most of which remain incurable. IDH mutant (IDHm) gliomas are a form of malignant brain cancer. IDH gliomas are more common in younger adults, are initially sensitive to chemotherapy and radiation, yet universally result in lethal recurrence following variable periods of remission. These vexing clinical features of IDHm glioma are partially explained by multiple recently described mechanisms through which IDHm tumor cells escape surveillance by the human immune system. Using mouse models and tumor samples derived from human patients, our group has discovered defective signaling in the Retinoic Acid pathway as a major driver of tumor-induced immune escape. Remarkably, clinical regimen containing All-Trans Retinoic Acid and Immune Checkpoint Inhibitors cure aggressive IDHm gliomas in an immunocompetent mouse model. This recent discovery led to a human clinical trial, recently opened at the University of Pennsylvania, to investigating All-Trans Retinoic Acid and Retifanlimab (a PD-1 inhibiting monocloncal antibody) in patients with recurrent IDHm glioma. Despite this promising development, several substantial questions regarding the mechanism of ATRA action remain unanswered. In this proposal, we set out to answer some of those questions by identifying the specific immune cells responsible for the therapeutic activity of All- Trans Retinoic Acid in IDHm gliomas. Equally importantly, we propose a thoroughly designed set of experiments in mouse models to predict response to ATRA and ATRA+Immune Checkpoint blockade, particularly in patients who receive ATRA or ATRA+Immune Checkpoint blockade prior to surgical resection as part of our trial. This proposal leverages recent advances in immune profiling of tumor tissue and circulating blood immune cells to carefully dissect immune cell populations and genetic signatures that are required for response to therapy in IDHm glioma and provide a readout for immunotherapeutic efficacy of ATRA and potentially other immune-directed therapies in IDHm gliomas. If successful, our proposal will contribute several important data points to help advance the discovery of additional immunotherapeutic strategies to substantially extend the lives of patients with IDHm glioma.